Core B: Translational, Cellular and Molecular Analysis

ABSTRACT – CELLULAR IMAGING AND GENOMICS CORE B
Core B, the Cellular Genomics and Imaging Core (CGI), will provide centralized experimental processing
services and primary data analysis for the Program Project Grant (PPG). The interactions between Projects 1, 2
and 3 primarily involve shared biospecimens and data; therefore, the PPG relies on the CGI to coordinate:
(1) Experimental and translational sample management.
(2) Cellular genomics that includes RNA-seq, single cell genomics and spatial transcriptomics.
(3) Imaging studies for cellular characterization of primary tissue cultures.
(4) Sample, molecular and genomic data management.
The CGI core enables the PPG to leverage the combined expertise of molecular technologists, cellular
biologists, imaging experts and informaticians to streamline data production. Biospecimens of human tissue
biopsies and organoids will be tracked in a laboratory information management system (LIMS). These samples
will be processed using standard operating protocols optimized by the CGI to facilitate reproducibility and
consistency across all projects. These protocols will cover confocal microscopy imaging, RNA-seq, targeted
DNA sequencing, spatial transcriptomics and single cell RNA sequencing. The CGI will produce a
comprehensive landscape of the gastric microenvironment across a range of precancerous conditions and work
in tandem with Core C for data analysis to further the PPG overall aims. The molecular, genomic and epigenetic
characterization will allow investigators to conduct numerous studies on the drivers of gastric cancer and
hypothesize methods for precision cancer interception.

Public health relevance
PROJECT NARRATIVE – CELLULAR IMAGING AND GENOMICS CORE B Core B's experimental processing services will determine the cellular and genomic features defining high risk gastric precursors. The core will support experimental models to define the underlying biology. By providing a range of sophisticated imaging, molecular and sequencing assays, the core will streamline the progress of the Program Project Grant and its goal of advancing precision cancer detection.